Academic Rheumatology and Clinical Immunology

PROJECT SUMMARY
The overall goal of the Research Track of the Rheumatology Training Program at UCSF is to
provide advanced research training to qualified physician-scientists who plan to pursue research
careers focusing on the rheumatologic diseases. This program provides training in basic and
clinical sciences important to the study of these diseases, drawing on the skills of nationally
renowned faculty who have a track record of mentorship. The main program is a direct research
experience under the close supervision of a primary faculty member as well as a mentoring
committee. Trainees will learn state-of-the-art methods and techniques; investigate a problem in
depth; determine what constitutes quality science; learn the latest scientific advances in their
field of study; understand the ethical conduct of research; and receive training on how to
disseminate their work. The program emphasizes approaches from disease pathogenesis to
translating research discoveries into improved recognition, health care delivery and treatment
for those with rheumatic diseases. Drawing on the significant strengths and resources of the
Rheumatology Divisions at Moffitt-Long University Hospital (Parnassus Heights campus),
Zuckerberg San Francisco General Hospital, and the San Francisco VA Medical Center, and
integrating the UCSF Division of Pediatric Rheumatology, the program supports physician-
scientists training in both adult and pediatric rheumatology. The program also draws upon the
strength of the Immunology Thematic Area within the Biomedical Sciences Program to provide
trainees with access to leading immunology researchers and a broad range of basic and
translational research and training opportunities in a highly collaborative environment. The
program has added new faculty in recent years, including several involved in clinical and
translational research, further emphasizing our focus on disease-related research and
increasing the transdisciplinary opportunities for trainees in areas of new research development.
For over four decades, the rheumatology training program has combined strength in basic
biomedical research with clinical and translational research and created an outstanding
environment for collaboration among faculty and trainees. This training grant will support five
highly qualified physician-scientist trainees through two years of rigorous scientific training, with
the objective that they will successfully devote their subsequent careers to the study of the
rheumatologic diseases.

Public health relevance
PROJECT NARRATIVE The rheumatologic diseases are a diverse group of conditions that together result in a large burden of disease in the United States and can lead to considerable morbidity, disability, lost work and premature death. The causes of these diseases remain poorly understood and there is a need for better therapies. This application will support the UCSF rheumatology research training of physician-scientists that for over 40 years has trained a cadre of the nation's leading researchers to address pressing questions that advance our understanding and treatment of rheumatic diseases.